SAFEY AND EFFICACY OF ESTROGEN IN HYPERPROLACTINEMIC AMENORRHEA

This study will determine the effects of chronic estrogen administration on tumor size, bone density, serum lipids, and pulsatile prolactin secretion in women with hyperprolactinemic amenorrhea.